Enhancing engagement and participation of marginalized community residents in the UAS

Project Summary.
The overarching goals of this supplement are to understand: (a) how to enhance engagement and participation
of hard to reach populations in the UAS, and (b) what is currently missing in our understanding of the sources
of inequality due to the lack of representation from certain parts of the population. We will conduct focus
groups and in-depth interviews to understand barriers to, and facilitators of, participation in the UAS for
populations in disadvantaged communities, as well as to understand current knowledge gaps, with the intent to
then develop and test (and eventually implement) a strategy for increasing their representation in the UAS. To
be sure, there is no assumption that eventually all interviews will be self-administered and web based. Both the
interview mode and questionnaire content will be determined by our findings in this project. Our specific aims
are as follows:
Aim 1: Investigate the challenges with the UAS’ current recruitment process, survey modality, and frequency for
marginalized populations.
Aim 2: Enhance understanding of how the UAS should investigate how inequality accumulates over the life course
among marginalized groups
Aim 3: Develop a strategy for increasing representation of individuals from marginalized populations into the UAS

Public health relevance
Project Narrative. The overarching goal of this supplement will be to learn what is the best way of understanding how inequality accumulates over the life course for underrepresented groups. A possible outcome is that we will identify specific groups and communities that need different interview modes and different content to supplement or cross validate what is being collected in the main web based UAS.